Instruments for Micro-Magnetic Stimulation of the Brain in Animals

DESCRIPTION (provided by applicant): We propose to evaluate the functionality, MRI- and bio-compatibility of probes for microscopic magnetic stimulation (mMS), a new brain stimulation technology. Moreover, it has been demonstrated that the orientation of the applied μMS fields (relative to the excitable tissue) provides unique activation of neuronal elements not seen with traditional electrical stimulation, a property that can be leveraged to improve experimental or therapeutic goals. This information will be used to develop a new product line for animal neuroscience research. These findings will provide a rationale for the further exploration of μMS as a prospective tool for clinical and preclinical applications which will be commercialized by FHC, a company with a 42-year history of successfully marketing to the research neuroscience market. The goal will be to further stimulate both development of μMS technology as well as the understanding of brain function.

Public health relevance
PUBLIC HEALTH RELEVANCE: Electrical and transcranial magnetic stimulation (TMS) have proven beneficial for patients suffering from a range of neurological disorders in spite of a number of efficacy, safety and practical limitations which exist for these therapies. The proposed microscopic magnetic stimulation (�MS) research system utilizes a novel neuronal stimulation pathway and may have implications for the design of new and improved stimulation therapies. The products (probes and generator) will be commercialized by FHC who will actively market it to research and clinical neuroscience customers.